Phosphodiesterase 4 mediated pathogenic mechanisms in alcohol associated liver disease

2.5% of United States population is affected by alcohol-associated liver disease (ALD), which represents the
eighth most common cause of mortality. Despite significant progress in the field, the complex mechanisms
driving the onset and progression of ALD are still not fully understood. cAMP is a second messenger that plays
a critical role in regulating multiple cellular functions via its effectors (e.g. protein kinase A). Amplitude and
duration of cAMP signaling is fine-tuned by phosphodiesterases (PDEs) via cAMP hydrolysis and degradation.
Our work has shown that ethanol increases expression of hepatic PDE4 in experimental ALD as well as in
alcohol-associated hepatitis (AH) patients’ livers. However, their role in ALD pathogenesis is not clear. We
started elucidating the role of PDE4s in ALD by demonstrating that Pde4b plays a critical role in ethanol-
mediated impairment of fatty acid β-oxidation and steatosis. We also showed that inhibition of PDE4 activity
attenuates liver injury in in vivo and in vitro models of ALD. However, underlying mechanisms of ethanol
mediated induction of PDE4 enzymes have not been determined. Moreover, how PDE4 inhibition exerts its
beneficial effect on dysregulated lipid metabolism and hepatocytes survival is not fully understood. Our
preliminary studies using animal and cell models of ALD identified novel pathways of ethanol and PDE4-
mediated regulation of hepatic lipid metabolism and cell injury which have never been examined before. Based
on our previous work and preliminary data, our central hypothesis is that ethanol via cytochrome p450
(CYP2E1) mediated increase in hypoxia inducible factor 1 (HIF1α) induces hepatic PDE4 which
contributes to dysregulation of hepatic lipid metabolism and injury.
The specific objectives of these mechanistic studies are to:
Aim 1: Determine the underlying mechanisms of PDE4 upregulation by ethanol in hepatocytes.
Aim 2: Determine mechanisms underlying ethanol/PDE4-mediated de novo lipogenesis and hepatic
steatosis.
Aim 3: Determine the role of MKP1 in ethanol/PDE4-mediated toxicity in hepatocytes.
The ultimate goal of this application is to identify not only the mechanisms of PDE4 upregulation, but also the
role of PDE4s in the development of ALD. Importantly, we predict that these preclinical studies will provide
strong rationale using PDE4 specific inhibitors in the treatment of ALD. Importantly, there are potent PDE4
inhibitors that are already FDA-approved for the treatment of other inflammatory disease processes, and these
inhibitors could potentially be repurposed for ALD.

Public health relevance
Project Narrative About 2.5% of the US population is affected by alcohol-associated liver disease (ALD), which represents the 8th most common cause of mortality. Currently there is no FDA approved therapy available for the treatment of ALD. This project will examine phosphodiesterase 4 (PDE4)-mediated pathogenic pathways in ALD. The findings of this project will lead to the development of novel therapies targeting PDE4 for treatment of ALD.